Clinical and Autonomic Effects of Mind-Body Exercise in COPD

DESCRIPTION (provided by applicant): Chronic obstructive pulmonary disease (COPD) is a major public health problem and is the fourth leading cause of death in the United States. Despite pharmacologic and surgical therapy, COPD continues to cause considerable morbidity and mortality and is the only major disease among the top ten that continues to increase in prevalence. Novel and inexpensive interventions that can improve symptoms, health-related quality-of-life, functional capacity, and potentially modify disease progression are needed. Tai chi is a popular mind-body exercise that combines gentle physical activity, self awareness, and relaxation with slow mind-body breathing. It may be particularly suited to deconditioned individuals with COPD, who suffer from limited exercise tolerance and shortness of breath on exertion, and it integrates multiple components relevant to COPD management, including low-intensity aerobic exercise, stress management and slow mind-body breathing training. In this application, we propose a 3-arm randomized controlled trial (N=102) to evaluate the benefits of tai chi exercise (which includes mind-body breathing) versus seated mind-body breathing alone (an isolated, key component of the comprehensive tai chi program) versus education control. This design will allow us to examine the individual efficacy of each mind-body intervention on clinical outcomes in COPD, but will also allow clinical and physiological comparisons between the two interventions, providing insight into the components and mechanisms of mind-body therapies. Patients with COPD (Global Obstructive Lung Disease stages 1-3 with symptoms of dyspnea) will be recruited from outpatient primary care and pulmonary clinics. Our primary aim will be to examine the effects of tai chi and mind-body breathing on quality-of-life and exercise capacity in this population. Secondary aims will further explore the effects on clinical symptoms, psychosocial indices, cardiopulmonary function, strength and flexibility, biomarkers of systemic inflammation, and autonomic activity. The results of our proposed research will help inform clinical treatment of COPD, and further our mechanistic understanding of mind-body exercises and the role of slow, mind-body breathing.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic obstructive pulmonary disease (COPD) is a major public health problem and is the fourth leading cause of death in the United States. This proposed study examines tai chi, a promising mind- body exercise, and one of its key components, slow mind-body breathing, that may be particularly relevant and beneficial to patients with COPD. The results of this study will help inform clinical treatment of COPD, and further our mechanistic understanding of mind-body therapies in general and the role of slow mind-body breathing. 7. Project Narrative: Chronic obstructive pulmonary disease (COPD) is a major public health problem and is the fourth leading cause of death in the United States. This proposed study examines tai chi, a promising mind- body exercise, and one of it key components, slow mind-body breathing, that may be particularly relevant and beneficial to patients with COPD. The results of this study will help inform clinical treatment of COPD, and further our mechanistic understanding of mind-body therapies in general and the role of slow mind-body breathing. __SpecificAimsTextDelimiter__ 2. Specific Aims Chronic obstructive pulmonary disease (COPD) is a major public health problem and is the fourth leading cause of death in the United States. Despite pharmacologic and surgical therapy, COPD continues to cause considerable morbidity and mortality. Given smoking trends, these clinical burdens are expected to increase. Novel interventions that can improve symptoms, health-related quality-of-life (HRQL), functional capacity, and modify disease progression are needed.1 Current models of the disease regard COPD as not just a disease of the pulmonary system, but as a systemic condition, involving marked autonomic dysregulation, which may mediate extrapulmonary effects such as systemic inflammation, skeletal muscle dysfunction, and cardiovascular risk.2 In addition, derangements in autonomic cardiopulmonary dynamics may contribute to the pathophysiology of dyspnea and a decrease in exercise capacity, which can worsen functional status and HRQL. Conventional exercise and breathing techniques as part of pulmonary rehabilitation programs have been shown to improve symptoms and HRQL. However, pulmonary rehabilitation has been underutilized, long- term adherence is poor, and it is clear that benefits diminish over a short period of time if patients do not continue to exercise.3 Thus, novel strategies that target the pathophysiology of disease as well as improve exercise adherence are needed. We propose to examine a multi-component mind-body exercise (tai chi) which has not been rigorously studied in patients with COPD despite increasing popularity among the general public. With origins in Chinese healing and martial arts, tai chi integrates gentle physical activity, self awareness, and relaxation with slow mind-body breathing. It may be particularly suited to deconditioned individuals with COPD who suffer from limited exercise tolerance and dyspnea as it integrates multiple relevant components, including low-intensity aerobic activity, stress management and slow mind-body breathing training. Data from our pilot investigations suggest that tai chi may be a promising adjunct to medical therapy for patients with COPD that is safe and enjoyable, and may improve exercise capacity and disease-specific HRQL. Further research by our team and others suggest that slow mind-body breathing- a key component of tai chi- can have profound effects on cardiopulmonary dynamics and autonomic tone. Our studies in patients with chronic heart failure also suggest that tai chi may impact both autonomic activity and overall function and HRQL.4,5 Sophisticated techniques used to assess autonomic tone, including heart rate variability as an index of cardiac vagal outflow make it possible to reliably measure and make inferences about the effects of mind-body interventions on autonomic activity. In this application, we propose a 3-arm randomized controlled trial to evaluate the benefits of tai chi exercise (TC) versus seated, slow mind-body breathing (MBB, an isolated component of the comprehensive tai chi program, which is particularly relevant as an intervention for COPD) versus an attention-matched education control in patients with COPD. This design will not only allow us to examine the individual efficacy of each mind-body intervention on clinical outcomes in COPD, but will importantly allow clinical and physiological comparisons between the two interventions, providing valuable insight into the contributory components and mechanisms of mind-body exercise. The overarching goals of our research are thus two-fold: 1) To determine the benefits of a TC program (which integrates MBB) and of MBB alone on patient-centered clinical outcomes in patients with COPD; and 2) To better understand the psychosocial and physiologic mechanisms of mind-body exercise. Primary Aim: 1. To determine the clinical efficacy of a 12-week TC program and of a 12-week MBB program on disease- specific HRQL and exercise capacity in patients with COPD, as compared to an education control; and to compare the effects of the comprehensive TC program to MBB alone. Hypothesis 1: Patients in the TC group will exhibit greater improvements at 12 weeks in our two primary outcome measures, the Chronic Respiratory Questionnaire and six-minute walk distance, than patients in the MBB group, while patients in both intervention groups will do better than the education control. Secondary Aims: 2. To examine the psychosocial and physiological effects of a 12-week TC program and of a 12-week MBB program by assessing a) symptoms of dyspnea, mood, perceived stress, self-efficacy, social support, b) cardiopulmonary function and exercise capacity, c) physical strength and flexibility, and d) biomarkers of systemic inflammation in patients with COPD, as compared to an education control; and to compare the effects of the comprehensive TC program to MBB alone. Hypotheses 2: Patients in the TC group will report greater improvements in a) the University of California San Diego Shortness of Breath Scale, Center for Epidemiological Studies-Depression Scale, Perceived Stress Scale, COPD self-efficacy scale, and Multidimensional Scale of Perceived Social Support, b) peak oxygen uptake and exercise duration on a cardiopulmonary stress test, lung volumes (reduced hyperinflation) c) clinical measures of strength and flexibility, d) serum levels of C-reactive protein, TNF- alpha, and IL-6, as compared to patients in the MBB group, while patients in both intervention groups will do better than the education control. 3. To further explore the mechanisms of mind-body exercise by assessing physiologic effects of a 12-week TC program and of a 12-week MBB program on autonomic indices (heart rate variability) in patients with COPD, and to determine whether changes in autonomic indices are associated with clinical outcomes. Hypotheses 3: a) Patients in the TC group will demonstrate the greatest increase in heart rate variability followed by patients in the MBB group, while those in the education control will demonstrate little or no change; b) Greater improvements in these indices will be correlated with greater changes in cardiopulmonary function, exercise capacity and HRQL.